Integrating Machine Learning and Physician Expertise for Breast Cancer Diagnosis

DESCRIPTION (provided by applicant): The goal of this research is to develop novel machine learning techniques to integrate physician expertise and machine learned, logical rules in a graphical model that will accurately estimate breast cancer risk after breast biopsy. Our multidisciplinary team has a track record (including NIH funding and publications in the medical and computer science literature) illustrating an innovative research program that merges cutting edge machine learning algorithms including inductive logic programming and statistical relational learning to train graphical models to predict breast cancer risk. However, in contrast to prior work, we are testing a completely new methodology which we call Advice-Based-Learning (ABLe). By developing ABLe, our team aims to establish an innovative, collaborative cycle between machine-learning and physician expertise. We propose to test the hypothesis that this cycle will increase accuracy beyond what either the machine or human can accomplish alone. Specifically, we hypothesize first that a conventionally-trained graphical model trained with conventional machine learning first algorithms can accurately predict the risk of breast cancer after core biopsy and perform better than current clinical practice; a critical aim that is favorably foreshadowed by our new preliminary data but is labor intensive because we must perfect our unique clinical data that accurately represents clinical experience. Second, a graphical model trained using ABLe can incorporate multi-relational data with physician expertise and significantly improve the predictive accuracy over conventionally trained graphical models and current clinical practice. Third, our best graphical model trained with ABLe will accurately estimate the probability of malignancy after breast biopsy on new clinical cases better than physicians alone resulting in a tool that has the potential to improve care. Our clinical application is as compelling as our algorithmic work. Image-guided core needle biopsy of the breast is a common procedure that is imperfect, has high-stakes, and is particularly amenable to improvement with automated decision support. Breast core biopsy, the standard of care for breast cancer diagnosis, can be non-definitive in 5-15% of women undergoing this procedure. This means that between 35,000-105,000 women will require additional biopsies or radiologic follow-up to cement a diagnosis and risk the possibility of missed breast cancers, delays in diagnosis, and unnecessary surgeries. This important problem is emblematic of a plethora of clinical situations where rigorous and accurate risk estimation of rare events provides the opportunity for automated decisions support tools to personalize and strategically target health care interventions to improve decision-making for health-care providers and patients. This award will enable us not only to produce graphical models that provide improved decision support in the breast cancer clinic, but also, and more significantly, to develop a methodology that integrates heterogeneous predictive data and physician knowledge within a graphical model, thereby developing and validating a new algorithmic paradigm for creating accurate, comprehensible, adaptable decision support tools well-suited for clinical translation.

Public health relevance
PROJECT NARRATIVE Our multidisciplinary group of breast cancer physicians and computer scientists propose to develop a new paradigm for construction of clinical decision support tools that will integrate machine learning (computers learning from data) and physician expertise in order to perform better than either alone. Our system will be able to accurately estimate the true risk of malignancy after breast core biopsy addressing the challenges of delays in diagnosis and unnecessary surgeries encountered on the road to early breast cancer diagnosis. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The goal of this research is to integrate physician expertise and machine learning into graphical models that will accurately estimate breast cancer risk after image-guided breast biopsy, in order to address the problem of biopsy sampling error. Image-guided core needle biopsy of the breast is a common procedure that is imperfect, has high-stakes, and is particularly amenable to improvement with automated decision support. The term graphical model describes Bayesian Networks (BN), which we highlight in our preliminary work, as well as Markov Networks, Markov Logic Networks, and others. We propose to develop a novel methodology for building decision support systems called Advice-Based-Learning (ABLe) that will iteratively combine heterogeneous clinical data using a probabilistic form of inductive logic programming (ILP) and expert physician knowledge to train accurate graphical models designed specifically for clinical translation. Image-guided core biopsy is the standard of care for the diagnosis of a suspicious finding in the breast. Unfortunately, the assessment of malignancy risk following breast core biopsy is imperfect and biopsies can be "non-definitive" in 5-15% of cases (7-13). A non-definitive result means the chance of malignancy remains high due to possible sampling error (i.e. obtained biopsy is not representative of the suspicious finding), for which surgical excisional biopsy or aggressive radiologic follow-up is proposed. "Non-definitive" biopsies may therefore result in missed breast cancers (false negatives) and unnecessary interventions (false positives). In the US, the 112 million women over the age of 20 years (14) have an annual breast biopsy utilization rate of 62.6 per 10,000 women, translating to over 700,000 women undergoing breast core biopsy in 2010 (15). As a result of "non-definitive" biopsies, approximately 35,000-105,000 of these women will require additional biopsies or follow-up secondary to judged inadequacy of breast core biopsy. This important problem is emblematic of a plethora of clinical situations for which rigorous and accurate risk estimation of rare but high- stakes events is critically important. Graphical models that accurately predict disease have the potential to enhance clinician decision-making and provide the opportunity for shared decision making with patients in order to personalize and strategically target health care interventions. However our goals reach far beyond our important domain of application. We aim to develop an innovative methodology, ABLe, that can create clinical decision support tools using a collaborative cycle between machine-learning and physician expertise. Our multidisciplinary team has a track record of developing graphical models from multi-relational data (5, 16-17) to calculate the risk of breast cancer based on data derived from multiple tables (e.g. demographic risk factors, mammography features and pathology data). While graphical models have the potential to aid in clinical reasoning, the multi-relational nature of these sources is challenging for conventional machine learning algorithms. The foundation of our prior work in "view learning" will empower ABLe as we use derived fields or tables - a new view of the database - automatically built by constructing logical rules using Inductive Logic Programming (18-20).The present proposal represents a critical and innovative extension of our prior work by tightly coupling machine-learned and human-constructed rules in an interactive cycle to improve our graphical models. However, our past successes must not inadvertently obscure the innovation inherent in the ABLe methodology; a technique that has not been tried in the medical domain and that has the potential to substantially improve the clinical accuracy of our graphical models. This award will enable us not only to produce graphical models that provide improved decision support in the breast cancer clinic, but also, and more significantly, to develop a methodology that integrates heterogeneous predictive data and physician knowledge within a graphical model, thereby developing and validating a new algorithmic paradigm for creating accurate, comprehensible, adaptable decision support tools well-suited for clinical translation. AIM 1 - Develop a graphical model for breast core biopsy using conventional training algorithms HYPOTHESIS: A graphical model trained with conventional machine learning algorithms can accurately predict the risk of breast cancer after core biopsy and perform better than current clinical practice. AIM 2 - Improve our graphical model for breast core biopsy using advanced training algorithms HYPOTHESIS: A graphical model trained using ABLe will incorporate multi-relational data with physician expertise and thereby significantly improve the predictive accuracy over conventionally trained graphical models and current clinical practice. AIM 3 - Demonstrate that our best graphical model has the potential to improve care HYPOTHESIS: Our best graphical model will accurately estimate the probability of malignancy after breast biopsy on new clinical cases better than physicians and thus have the potential to improve care.